Axonal and synaptic transformations of melanopsin retinal ganglion cell output

PROJECT SUMMARY/ABSTRACT
Animals rely on visual information to interact with their environment. In contrast to visual perception, other
visual functions benefit from a temporally and spatially blurred version of the surroundings – one that is
sensitive to overall illumination (irradiance) instead of image detail. In mammals, these functions rely on
intrinsically photosensitive retinal ganglion cells (ipRGCs) which sense light directly due to their expression of
the photopigment melanopsin. There is evidence that the M1 type of ipRGC is required for a wide range of
non-image-forming visual functions such as setting of circadian phase, control of the pupil, and even regulation
of mood. These mechanisms of physiological control appear to be dependent on a measure of irradiance.
Indeed, our lab has shown that M1s are exceptionally well-suited to encode environmental irradiance thanks to
efficient temporal integration and population level responses that span the physiological range of light
intensities. That said, previous studies of M1 ipRGCs have focused on the somatodendritic compartment. The
hypothesis driving this proposal is that axonal and synaptic specializations make M1s even more effective at
encoding and transmitting irradiance information than is currently appreciated. Aim 1 will explore the functional
consequences of axonal melanopsin expression. M1 axons can travel long distance (>1mm) within the retina
where they are subject to natural light stimulation. My preliminary data suggest that the axons can sense light
and generate action potentials independently of the soma. I will explore the ways in which this axonal
photosensitivity augments the output of M1s. Aim 2 will explore how synaptic properties further transform the
output of M1s and dictate how they drive downstream circuits. M1s have been identified as vital for two
regulatory behaviors in particular: circadian control (mediated by the suprachiasmatic nucleus; SCN) and
pupillary control (mediated by the olivary pretectal nucleus; OPN). M1s control circadian phase on slow
timescales (hours to days) but control the pupil on fast timescales (seconds to minutes). I will explore the
features of the M1 synapse, in combination with those of the postsynaptic cells of the SCN and OPN, that
enable M1s to drive these qualitatively and quantitatively disparate behaviors. Together, these experiments will
inform our understanding of how ipRGCs encode and transmit photic information and will add to our basic
understanding of the biophysical mechanisms underlying neuronal signaling.

Public health relevance
PROJECT NARRATIVE This project concerns how a mammalian photoreceptor generates, transforms, and transmits information that drives a range of processes such as the regulation of sleep, circadian rhythms, and mood. The proposed experiments will characterize how specific properties of this photoreceptor make it especially well-positioned to collect environmental information and drive downstream circuits. The knowledge gained in this project is likely to generalize to other neurons and has the potential to inform how we design artificial lighting for health and treat ocular diseases.